Supportive, Multidisciplinary Addiction Research Training (SMART)

ABSTRACT
This is a new T32 application entitled “Supportive Multidisciplinary Addiction Research Training (SMART)”. The
broad goals of this program are to provide training in substance use disorder (SUD) research for postdoctoral
fellows engaged in translational research spanning very basic research programs to clinical trials. This T32 will
provide complementary training opportunities to ongoing large translational research efforts at the University of
Pittsburgh including the NIDA funded Center for Adolescent Reward, Rhythms and Sleep (CARRS), The
Adolescent Brain Cognitive Development Study (ABCD), Bridging Connections in Addiction Research (BCAR)
and the Center of Excellence for Computational Drug Abuse Research (CDAR). This T32 will allow postdoctoral
trainees to engage with both their primary mentor and a host of transdisciplinary faculty across the University of
Pittsburgh campus. Our university has a rich history in SUD research including multiple nationally and
internationally recognized experts in the field. Trainees will have the opportunity to learn from each other and a
multidisciplinary team through mentored laboratory training, journal clubs, didactic work and clinical experiences.
We will also provide support for trainees to present their research both here at university sponsored events such
as Pitt Psychiatry Research Day, and at national and international conferences such as the Society for
Neuroscience, The College on Problems of Drug Dependence and the Neurobiology of Addiction Gordon
Research Conference. We also provide unparalleled professional training through our weekly postdoctoral
Career & Research Development Seminars (CARDs) and associated writing blocks, giving trainees the
opportunity to gain valuable feedback on grant proposals from both faculty and their peers. This T32 will benefit
from both a University Advisory Board and an External Advisory Board which will provide yearly evaluations to
help strengthen our program. Trainees will regularly engage in training in the responsible conduct of research
provided here through the University of Pittsburgh Clinical and Translational Science Institute (CTSI). We are
highly committed to the training of underrepresented groups in biomedical research and plan not only targeted
recruitment but also enhanced mentor training and regular discussions of potential bias and obstacles to success
that trainees may encounter. In sum, our goal is to provide a diverse, inclusive, intellectual experience that will
provide the necessary skill set for a successful career in translational SUD research.

Public health relevance
PROJECT NARRATIVE Research into the causes of SUD has led to the identification of multiple factors that contribute to vulnerability and the hope for better treatments in the future. For this to continue we need to actively train the next generation of addiction researchers in multidisciplinary, translational approaches such that treatments can move forward from the bench to the clinic. The aim of this T32 is to provide these opportunities to postdoctoral researchers who plan to have a career in SUD research.